Dissecting the Stromal-Immune Interactions that Lead to Photosensitivity (Project 2)

ABSTRACT/PROJECT SUMMARY (Project 2)
Ultraviolet (UV) light exposures are a frequent trigger for skin inflammation in patients with systemic lupus
erythematosus (SLE) or cutaneous lupus erythematosus (CLE) without systemic disease. Sufficient exposure
can also lead to increased systemic disease activity. The mechanisms driving photosensitive responses in lupus
patients are not well-understood yet are essential for developing strategies to prevent UV light from triggering
flares. This project of the University of Michigan Integrated Program for Cutaneous Immune-Stromal
interactions in SLE (IPCISS) will build upon an accomplished collaborative working group seeking to
understand the etiologies of CLE and SLE. Our ongoing work has identified a critical role for both
epidermal/stromal and immune cells in creating a pro-inflammatory milieu in SLE skin after UV exposure. Thus,
this project will address our overall hypothesis that dysregulation of stromal-immune interactions in the
skin of SLE patients contributes to inflammatory rather than tolerogenic responses to UV light leading
to cutaneous and systemic inflammation. This project will synergize with the Program's BIOPSII Core to
harness the power of integrative omics work on patient samples in conjunction with careful mechanistic study to
identify therapeutic targets for photosensitivity in SLE/CLE. Our specific aims are Aim 1: Map the infiltrate and
expression changes within SLE and HC skin after UV exposure. We will identify cellular sources of interferon
in the skin after UV exposure and use paired single-cell RNA sequencing and single-cell resolution spatial
profiling and functional follow-up to map signal crosstalk from keratinocyte, fibroblast, and endothelial cell
networks. We hypothesize that this spread of IFN signal begins in the KC and is transmitted to surrounding cell
populations which then transmit signals to induce cellular recruitment. Aim 2: Identify the role of UV-induced
extracellular vesicles (EVs) in driving KC-immune crosstalk. Our data support a role for type I IFNs in
increasing EV numbers and size after UV exposure. We hypothesize that KC-derived EVs are a critical mediator
of immune activation in SLE skin. Thus, we will explore the role of UV-induced EVs as a critical component of
paracrine and systemic signal delivery. Aim 3: Determine how UV exposure modulates inflammatory
memory within keratinocytes. Our data support unique dysregulation of histone methyltransferase pathways
in SLE KCs after UV exposure. We hypothesize that UV exposure in an IFN-rich environment, such as SLE skin,
results in histone methylation changes that open inflammatory gene transcriptional programs and could
potentially serve as an initiating factor in CLE predisposition. We will thus examine the impact of IFNs and UV
exposure on chromatin accessibility in SLE and healthy control KCs and utilize single nuclear/ATAC-seq
(multiome) to link inflammatory and epigenetic modifications after UV exposure in SLE, ANA+ without disease,
and healthy control subjects in vivo.